Validity of Diet and Activity Measures in Men

DESCRIPTION (provided by applicant): Large prospective studies of diet and cancer have often not supported hypotheses that were based on animal and ecological findings;one possible explanation could be large measurement errors in the assessment of diet. Thus, NCI had requested proposals for a series of collaborative validation/calibration studies imbedded in existing cohorts using a common design with multiple self-reported and biomarker measures of diet and physical activity including doubly labeled water (DLW), urinary nitrogen (UN) and motion monitors. We therefore propose to conduct such a study among 750 men. The proposed study will complement a very similar study that NCI is funding in women, utilizing many of the same methods, among participants in the Nurses'Health Studies. The two studies will provide substantial synergy. For the proposed study, 375 men will be participants in the ongoing Health Professionals Follow-up Study (HPFS), which will be of particular value because of the rich data already collected. The other 375 participants will be drawn from Harvard Pilgrim Health Care, a Boston-area HMO. This participant pool will permit a broader representation of the community, with oversampling of African-Americans, and the potential with linkage to the clinical database. In HPFS, we have already collected extensive dietary data using multiple measures of intake and plasma biomarkers of diet;this will allow the evaluation of the validity of dietary assessment methods over a 23-year period. The proposed study design will consist of two FFQ's one year apart;in the year between these measures we will collect four NCI automated self-administered 24-hour recalls (ASA24), two 7-day dietary records, and biomarkers of diet including one assessment of energy expenditure using doubly-labeled water (DLW), four 24-hour urinary measures of nitrogen (a measure of protein intake), sodium and potassium, and two fasting blood samples for assessment of fatty acids, standard lipids, carotenoids, and folate. Physical activity will be assessed twice (together with the FFQ's) by the modified Paffenbarger physical activity questionnaire, by four 24-hour recalls using an automated system developed by the NCI, twice by an objective physical activity monitor, and by DLW. In the 575 men from the Boston area (from the HPFS and the HMO), we will also assess DEXA and resting metabolic rate to refine energy expenditure measures. These multiple measurements will allow an evaluation of the error structure associated with dietary and physical activity assessment methods, in particular the influences of variation over time for each method and correlated errors between methods. This will provide information of the relative and absolute validity of the different measures, and inform the interpretation of the published literature on diet and cancer (allowing for measurement error correction) and the design of future validation/calibration studies. Additional analyses will indicate the optimal approaches to adjust nutrient intakes for total energy intake, which is critical for the interpretation of epidemiologic findings. PUBLIC HEALTH RELEVANCE: The proposed validation/calibration study will provide quantitative data on the validity of the methods that have been used in cohort studies to measure diet and physical activity. This information would greatly enhance the value of the data that have been collected and would also provide invaluable guidance for the design and collection of future data on diet and physical activity and cancer by other investigators, resulting in great benefit to public health.

Public health relevance
PROJECT NARRATIVE The proposed validation/calibration study will provide quantitative data on the validity of the methods that have been used in cohort studies to measure diet and physical activity. This information would greatly enhance the value of the data that have been collected and would also provide invaluable guidance for the design and collection of future data on diet and physical activity and cancer by other investigators, resulting in great benefit to public health.